Molecular mechanisms regulating and interpreting BMP signaling

The application seeks funding to purchase a Leica M165 FC Fluorescence Stereomicroscope
and associated accessories, together with a camera, a computer and imaging software. The
entire package is essential for our proposed research in dissecting mechanistically how various
proteins that we have identified function to regulate the BMP signaling pathway. It will improve
our efficiency and throughput in body size measurement, the major output of BMP signaling in
C. elegans, and will significantly increase our research productivity.

Public health relevance
PROJECT NARRATIVE The highly conserved bone morphogenetic protein (BMP) signaling pathway plays critical roles in a variety of developmental and homeostatic processes. Defects in this pathway can result in various disorders, including cancer, as well as musculoskeletal and cardiovascular diseases. Identifying regulators and targets of BMP signaling and determining how they function in vivo will not only yield critical insight into our general understanding of development and diseases, but may also help identify potential therapeutic targets for the diseases caused by mutations in the BMP pathway.